Disrupting the mosquito larval midgut using novel pH responsive compounds

Project Summary
Mosquito borne pathogens afflict millions of people worldwide and their prevalence is anticipated to
increase as mosquitoes and their pathogens become resistant to currently available drugs and insecticides.
While drugs can be used to treat some mosquito borne pathogens, a majority of transmission control comes
through targeting the mosquito vector itself. While insecticides targeting both adult and larval stages are
available, larvicides have the advantage of targeting a constrained target that is unable to readily evade
treatment. Unfortunately, only a few larvicides are available for use and their modes of action are limited.
Thus, there is a critical need for selective novel larvicides with additional modes of action. We have developed
two novel delivery systems that target the uniquely high pH levels of the larval gut. We hypothesize that
provisioning these compounds to immature mosquitoes will allow us to induce lethal effects in mosquitoes of
medical importance. Through a recursive set of aims whereby compounds are readily synthesized, tested and
evaluated we will test this hypothesis in two important mosquito vectors, the malaria vector Anopheles
stephensi and the arboviral vector Aedes aegypti. In Specific Aim 1 we assess the activity of pH responsive
compounds that are tuned to the unique larval midgut environments of Aedes aegypti and Anopheles
stephensi mosquitoes. An initial set of compounds developed by our lab in the MaMa and PTBD classes will be
provisioned to larvae and their efficacy will be assess through SDS-PAGE, imaging, and proteomic studies. In
Specific Aim 2 we will determine the ability of pH sensitive compounds to negatively impact larval
development and deliver larvicidal compounds specifically to the midgut of immature mosquitoes. Compounds
developed to perturb the larval gut will be evaluated for any deleterious effects that they have on the mosquito.
In depth studies of their metabolism, membrane integrity, and larval and adult fitness will be conducted. By the
end of this study, we will have assessed the activity of two chemically distinct sets of compounds in the midgut
of larval mosquitoes. The long-term goal is to develop flexible and highly mosquito-specific larvicidal
compounds with the capacity to leverage unique modes of action.

Public health relevance
Narrative Current control strategies for mosquito-borne pathogens largely rely on reducing mosquito vector populations using insecticides but this approach is becoming less effective as insecticide resistance develops against many mosquito adulticides and larvicides. We have developed novel pH responsive compounds capable of delivering a range of toxic payloads to the larval gut and its unique high pH conditions. This provides an opportunity to develop highly specific larvicides with minimal effects on non-target organisms and the flexibility to switch toxic compounds if resistance develops.